Role of synaptic density in mediating the relation between social disconnection and late-life suicide risk

PROJECT SUMMARY: Social disconnection (SDC) and suicide deaths are major public health concerns for
the aging population. SDC is one of the strongest risk factors of suicidal ideation, attempts, and deaths in older
adults, and is a modifiable target for suicide prevention efforts in this population. While accumulating evidence
has established an association between SDC and late-life suicide risk, the neural mechanisms that underlie
this association remain unknown. Consequently, our understanding of how to optimally intervene to mitigate
the adverse effects of SDC on suicide risk in older adults is limited. To address this gap, we propose to
conduct the first in vivo molecular imaging study of a potential neural mechanism – corticolimbic synaptic
density – that may mediate the link between SDC and late-life suicide risk. Given a higher prevalence of
suicide death in older men than women, we will also examine whether sex moderates this association.
Converging evidence from human magnetic resonance imaging and postmortem studies and preclinical work
suggests brain alterations in SDC and suicidality, with robust evidence implicating lower corticolimbic synaptic
density. In animal models of SDC, socialization appears to reverse some of these synaptic losses. These
studies have also observed sex differences in synaptic changes in interventions designed to reverse SDC-
related synaptic losses. Thus, it is critical to conduct in vivo human studies to evaluate molecular mechanisms
that may confer risk for suicide in older adults with SDC in order to identify who is at greatest risk and how to
mitigate burden of suicide to older adults, their families, and the community at large. In vivo quantification of
synaptic density in humans is possible with the radioligand 11C-UCB-J, which quantifies the density of synaptic
vesicle glycoprotein 2A (SV2A), a ubiquitously expressed marker of synaptic density, using positron emission
tomography (PET) imaging. Our preliminary data from a diverse sample of older adults confirm preclinical
findings of lower corticolimbic synaptic density in SDC and suggest sex-specific differences. In the proposed
study, we will recruit a transdiagnostic cohort of older adults presenting with the full range of SDC and evaluate
whether lower corticolimbic synaptic density mediates the relation between SDC and longitudinal trajectories of
late-life suicide risk in a sex-specific manner. We will employ a novel, data-driven approach to model
predominant trajectories of late-life suicide risk, which will include measures of suicide
depressive
and death ideation,
symptoms, loss of personal and self-worth, executive control, and perceived meaning in life.
Results of the proposed study will provide the first human in vivo data on the role of synaptic density alterations
as a putative neural mechanism linking SDC to late-life suicide risk. They will also inform the development and
testing of targeted interventions to enhance synaptogenesis (e.g., medications such as ketamine or
psychosocial interventions such as peer support), as well as public policies to promote social connection
among older adults who may suffer from illness or other issues that lead to SDC.

Public health relevance
PROJECT NARRATIVE Suicide among older adults is a significant public health concern, and social disconnection (SDC) has been identified as a key risk factor for suicide in this population. However, current understanding of neurobiological mechanisms implicated in SDC and suicide risk is limited, in part due to lack of mechanistic in vivo studies that are needed to identify modifiable targets for suicide prevention and intervention efforts. We propose to evaluate whether in vivo alterations in corticolimbic synaptic density may mediate the relation between SDC and longitudinal trajectories of late-life suicide risk, and whether this association differs in women vs. men.